Trichomonas vaginalis through the lifespan

PROJECT SUMMARY / ABSTRACT
Trichomonas vaginalis (TV) is the most prevalent non-viral sexually transmitted infection (STI) globally. For
reasons unknown, unlike other STIs, TV prevalence follows a bimodal population age distribution. Infection
increases risk of preterm birth, infertility, and cervical neoplasia and is associated with a striking health
disparity, with women of African descent disproportionately affected. TV infection increases the risk of HIV
transmission and acquisition. Despite the high prevalence and

Public health relevance
PROJECT NARRATIVE Trichomonas vaginalis (TV) is the most prevalent non-viral sexually transmitted infection globally, is associated with a number of adverse health outcomes, and has received comparatively little public health attention. We propose to examine the natural history of TV across the lifespan by characterizing the epidemiology, assessing risk factors associated with TV susceptibility, and profiling the local and systemic (immune/microbiota) effects of TV infection by life stage and HIV status. This work will shed light on the reasons for the curious bimodal age distribution in TV prevalence, the mechanisms by which the parasite induces disease and, ultimately, contribute to understanding the disproportionate adverse health outcomes in women of African descent and in the Southern United States.